Translational Research Support Core

PROJECT SUMMARY – Translational Research Support Core (TRSC)
To meet the diverse needs of researchers in the UC Davis Environmental Health Sciences Center (EHSC), the
Translational Research Support Core (TRSC) will focus on facilitating the pathway for translation of research
discoveries into interventions and policy that improve human health. UC Davis has recognized expertise in
animal and in vitro models in environmental health research that is housed in many basic and translational
laboratories across our schools and colleges. Leveraging these scientific resources, the TRSC will facilitate
access to the expertise and services necessary to move novel research findings along the translational
research pathway. In the next funding cycle, the TRSC will emphasize the implementation of novel tools and
technologies in human studies in environmental health, climate and disaster related research, and health
policy. Specifically, our aims are: 1) to disseminate novel tools and technologies for translational environmental
health research; 2) to expand human health studies in climate and disaster research, such as wildfires and the
pandemic, which can engage populations affected by environmental disasters; 3) to promote and expand
EHSC research projects along the Translational Research pipeline using in vitro assays, in vivo rodent to non-
human primate models, and human studies leading to public policy initiatives; and 4) to provide critical study
design and biostatistical consultation expertise to new and established environmental health researchers.
These resources are critical for the EHSC to achieve its overarching goal to deepen our understanding of how
environmental exposures affect human health; the TRSC will play a vital role in bringing EHS-related research
at UC Davis to people in California’s Northern and Central Valley, and throughout the world.